The Center for Actionable Variant Analysis; measuring variant function at scale

PROJECT SUMMARY
Nearly all of the ~9 billion possible single nucleotide variants compatible with life exist among the 7.8 billion
individuals alive today. Understanding the effects of these variants, especially in disease-associated protein
coding genes, is central to understanding human biology and to using genome sequence information to guide
the diagnosis and treatment of disease. Unfortunately, most new variants revealed by genetic testing are
variants of uncertain significance, meaning insufficient information exists to definitively interpret the variant as
either pathogenic or benign. Variants of uncertain significance cannot be used to guide patient care and reflect
our incomplete understanding of variant effects. To overcome this challenge, we developed saturation genome
editing (SGE) and variant abundance by massively parallel sequencing (VAMP-seq), multiplexed assays of
variant effect that can make and measure the functional effect of massive numbers of variants. In SGE, single
nucleotide variants are edited directly into the genome, revealing the effect of these variants on cell survival
due to effects on splicing or protein function, thereby enabling accurate identification of both pathogenic and
benign variants. VAMP-seq measures the effects of missense variants on protein abundance inside cells, and
can identify up to 80% of pathogenic variants. Together, SGE and VAMP-seq can be applied to at least 40% of
genes to produce high quality, clinically useful functional data at single nucleotide resolution. Already, variant
functional data produced by each of these methods are being used by clinicians to interpret genetic variants.
Our proposed Center for Actionable Variant Analysis (CAVA) will harness SGE and VAMP-seq to
contribute single nucleotide variant functional data for ~200,000 variants in ~32 of the most clinically
impactful protein coding genes to the IGVF Variant/Element/Phenotype Catalog. To accomplish this
transformative goal we propose four Aims. In Aim 1, we will choose target genes and assays using a
framework that maximizes clinical need, clinical impact and practicality. Each target/assay pair will be
rigorously validated prior to entering production. We will contribute to the Consortium during the first year and
beyond by developing standards, sharing reagents and initiating collaborative projects. In Aim 2, SGE and
VAMP-seq will be performed on ~32 genes to high quality standards tracked using well-defined metrics. These
include assay dynamic range and reproducibility, individual measurement error, and concordance with existing
functional data and gold standard clinical data. A data analysis pipeline, integrated with our LIMS, will ensure
reproducibility and enable careful progress tracking. In Aim 3, we will share the multiplexed variant functional
data. Rigorously defined data sharing standards and metadata will ensure discoverability, computability and
durability. We will work with the Consortium to achieve consensus and we will revise our plans accordingly. In
Aim 4, we will enable labs to quickly stand up SGE or VAMP-seq. We will create a predict-evaluate-revise cycle
that leverages the data we will generate and work collaboratively to generate data to improve modeling efforts.

Public health relevance
PROJECT NARRATIVE The interpretation of new variants, especially those revealed by genetic testing in the clinic, is difficult and hampers the use of genetic information to improve the diagnosis and treatment of disease. To empower variant interpretation, we propose the Center for Actionable Variant Analysis which would measure the effect of ~200,000 single nucleotide variants in ~32 of the most clinically important genes.